Heterochromatin Repair Mechanisms: a Chromatin Perspective

SUMMARY
About 10-30% of human and fly genomes comprises pericentromeric heterochromatin, a poorly characterized
component of the genome where defective repair of double-strand breaks (DSB) can trigger widespread aberrant
recombination and genome instability. Previous studies identified specialized mechanisms for “safe” homologous
recombination (HR) repair of heterochromatin, including a poorly understood role for “silent” chromatin marks.
The chromatin state is also deeply reorganized in response to damage in heterochromatin, but little is known
about the nature of these changes and their roles in repair. This lack of knowledge is a major barrier to
understanding how misregulation of this pathway contributes to cancer initiation and progression, and how
epigenetic therapies contribute to cancer recurrence. This proposal will fill this knowledge gap by illuminating the
role of chromatin composition and regulation in heterochromatin repair. We will test the hypothesis that specific
chromatin modifications and non-coding RNA synthesis coordinate HR progression in space and time to enable
faithful repair of heterochromatin. Specifically, this study will: 1) establish the role of ‘silent’ chromatin marks in
promoting early steps of heterochromatin repair; 2) identify chromatin changes and chromatin modifiers
responsible for repair progression in heterochromatin; and 3) define how damage-induced long non-coding RNAs
(dilncRNAs) contribute to heterochromatin repair. We are particularly well-positioned to conduct this research.
We pioneered the development of innovative approaches and tools that will be used for this study and we
generated robust preliminary results at the foundation of this proposal. A particularly creative and original aspect
of this research is the combination of unique strengths of the Drosophila system for the 3D analysis of
heterochromatin repair dynamics, with transformative tools for site-specific DSB induction and next-generation
sequencing, and with innovative in vitro assays. This unique combination of approaches will enable the first
systematic characterization of chromatin responses contributing to heterochromatic repair, significantly
advancing the understanding of genome stability mechanisms in multi-cellular eukaryotes. By establishing the
role of chromatin composition and regulation in heterochromatin repair, this study will contribute to understanding
essential mechanisms preventing cancer formation. This study will also help predict the consequences of
epigenetic treatments on genome destabilization and cancer recurrences. Misregulation of heterochromatin repair
is likely one of the most underestimated and powerful sources of tumorigenesis, and understanding
heterochromatin repair mechanisms is a necessary step for understanding cancer etiology and for developing more
effective approaches for cancer prevention, detection, and treatment.

Public health relevance
PROJECT NARRATIVE Understanding the cellular responses to DNA double-strand break (DSB) is central to understanding the mechanisms responsible for cancer formation, and to identifying more effective targets for early cancer detec- tion and treatment. Our studies aim to illuminate the epigenetic mechanisms responding to DSBs in hetero- chromatin, a poorly characterized domain occupying 30% of the human genome. Even though defects in these pathways lead to aberrant recombination, a leading force of genome instability and tumorigenesis, surprisingly little is known about DNA damage responses in this domain.